Life Course Center Program Development Core

Project Summary/Abstract
The primary aim of the LCC Program Development Core is to stimulate ground-breaking interdisciplinary
research that addresses the Center’s three key themes: (1) Later Life-Course Population Trends in Context; (2)
Life-Course Dynamics as Disparity Mechanisms; and
(3) Interrelationships of Work, Family, Community
Participation, and Health. Core B will fund pilot projects that bring together researchers from across the
University of Minnesota and from the LCC External Innovative Network Core. Priority will be given to early
career scholars and scholars from historically underrepresented groups and to proposals with high promise to
grow into externally funded projects. The Core will target the LCC’s 103 affiliates (many of whom are new to
research on aging), scholars of aging from across the University of Minnesota, and researchers from outside
institutions whom we will engage through our External Innovative Network Core. Core B will leverage the
assets of Core A to support proposal recruitment, review, and monitoring, including focused support for and
close monitoring of all research that involves human subjects.